Discovery and development of drug cocktails evolved by Nature

PROJECT SUMMARY
Discovery and development of new pharmaceuticals and therapeutic alternatives is required to
address rapid emergence of drug resistance. An attractive approach is to maximize the potential of
currently available drugs through combination therapy. However, de novo design of effective drug
cocktails has suffered from the limited understanding of their mechanisms of action or the tedious trial-
and-error methods. Moreover, drug resistance can even be aggravated by irrational and abusive usage
of noneffective drug cocktails. Therefore, a design strategy for effective cocktail recipe is needed.
Numerous observations have suggested that microbes have evolved a large collection of effective drug
cocktail recipes to fight against drug resistance after billions of years of natural selection. However,
besides a few known examples, co-produced natural products and their combinatorial potential have
been overlooked for decades. This is primarily due to the focus of the field on the biological activity of the
purified individual compounds, rather than the mixture itself. In addition, it is challenging to predict co-
produced natural products based on the genomes of the microbes that synthesize them. Moreover, the
synthesis of co-produced and synergistic natural products remains difficult. This MIRA grant will address
these challenges. The first research direction is to identify the synergies between intermediates and the
final antimicrobial natural products co-produced by single biosynthetic pathways. The structural similarity
between these compounds is expected to allow their binding towards the same targets, which can lead
to synergistic inhibition of drug-resistant microbes. By characterizing compounds biosynthesized through
the same pathways, it is expected to directly provide effective drug cocktail recipe against resistance and
to deepen the understanding of the design rules for combination therapy. The second research direction
is to address the challenge during the production of the synergistic compounds by dividing their
biosynthesis into two bacterial hosts, with one host producing the intermediate, the other producing the
final product. It is expected to have three advantages compared to the conventional biosynthesis using
a single bacterial host. First, this strategy will reduce the metabolic burden that each bacterial population
will experience, and thereby improve the overall production of the final products. Second, the titer ratio
of the synergistic intermediates and final products can be fine-tuned by manipulating only one bacterial
host, providing modularity during optimization process. Third, the system will produce the compounds
with the titer ratio showing the optimal synergistic effect, and then alleviate extensive compound isolation
and purification. Overall, the synergy of the two proposed research directions will lead to the discovery
of effective drug cocktail recipes against drug resistance, provide fundamental insights for the design
rules of combination therapy, and address challenges in the production of these compounds.

Public health relevance
PROJECT NARRATIVE Combination therapy has shown great promise in addressing the rapid emergence of drug resistance, but the development of effective drug cocktails is lagging due to the challenges in both design and production processes. We propose to address these challenges by identifying drug cocktails produced by individual biosynthetic pathways of microbial origin and overproducing these naturally evolved cocktails using a metabolic division of labor strategy.